R35 Equipment Supplement

ABSTRACT
Sepsis, burns and trauma are the most catastrophic and intractable challenges affecting our adult
population. Trauma, sepsis, and critical illness are diseases of the bone marrow, and we have now demonstrated
that many of the long-term complications and dismal clinical outcomes are secondary to ‘pathologic activation’
of myeloid populations. We were the first to report the expansion of MDSC subsets in sepsis, and have made
significant contributions to our understanding of these cell populations. Studies we have conducted by this
funding instrument have demonstrated that our definitions of MDSC phenotypes over-simplify and limit efforts to
prognose and treat MDSC-mediated disease. We recognize that our ongoing studies require a more granular
assessment of the function and phenotype of individual stem cell as well as myeloid and lymphoid cell
populations over time in patients with differential outcomes after sepsis, trauma and burns. To achieve that goal,
we require an increase in our capability to resolve and isolate individual MDSC subtypes. We currently are using
a Bio-Rad S3 fluorescently-activated cell sorter that is seven years old, and has 2015 technology. This includes
just two lasers, four colors and two side stream splitting. Our experience with the S3 has shown that we are
limited to approximately 20,000 drops/second and 1000 events/second making sorts a day-long procedure. More
problematic, Bio-Rad has informed us that they are discontinuing support for the S3 including parts. In its stead,
we are requesting support for the purchase of a Becton-Dickinson FACSMelody® BRV 9 Color 4 way flow
cytometer package including software, training and a one year maintenance contract. The advantages of the
FACSMelody® over the existing instrument are significant: three versus two lasers, nine colors instead of four
colors and four versus two side streams to simultaneously isolate at least two and likely three much higher
enriched subsets of MDSCs. Also important is sorting speed. Using the current instrument, whole blood sorts
take three to four hours per sample, and these times can be reduced five-fold with the new instrument. This not
only increases throughput, but improves the viability of the isolated cells, a key component of improved rigor and
reproducibility.
We envision analyzing samples from over 75 subjects annually (150-200 samples) based on the
proposed goals. Additional institutional resources guaranteed by the Department of Surgery/College of Medicine
will the service contract (~$25k annually) for the life of the grant award and the costs of additional reagents
required for the higher specificity (see attached letters). Through combined support from NIGMS and the
Department of Surgery and College of Medicine, the programmatic goals can be achieved with high rigor and
reproducibility.

Public health relevance
NARRATIVE Here we propose the purchase of a Becton-Dickinson FACSMelody® BRV 9 Color 4way Flow Cytometer to high throughput live cell sorting of myeloid derived suppressor cell (MDSC) subsets to support R35 GM140806, Pathological Myeloid Activation After Sepsis and Trauma. The cell sorter will be used on blood and bone marrow specimens obtained from sepsis and trauma patients. Data collected to date using existing cell sorting capabilities suggests that current definitions of MDSC subsets underestimate the true complexity of MDSC subsets in human sepsis and trauma.